Ultra low-input epigenetic sequencing with combined enzymatic and long-read technologies

PROJECT SUMMARY
This project seeks to advance epigenetic sequencing by combining novel enzymatic methods with long-read
sequencing technologies, allowing for the accurate resolution of epigenetic and genetic information across
extended DNA regions even in sparse, but biologically-important, genomic DNA samples. Traditional epigenetic
sequencing has heavily relied on bisulfite sequencing (BS-Seq), which, while effective for identifying 5-
methylcytosine (5mC), confounds this base with the opposing and second most common mark 5-
hydroxymethylcytosine (5hmC), and degrades DNA, limiting its use across long-ranges and in low-input samples.
Moreover, third-generation sequencing platforms, despite their ability to map long DNA fragments and detect
modifications directly, require high sample inputs, which constrains their application in critical areas, such as
single-cell analyses and circulating cell-free DNA (cfDNA) studies. Our project will focus on overcoming these
limitations by seamlessly integrating cutting-edge enzymatic approaches that permit the targeted conversion of
cytosine modifications with the capabilities of long-read sequencing to provide a more comprehensive view of
the epigenetic landscape. These technologies will be specifically tailored to handle ultra-low input samples
efficiently, addressing significant gaps in current methodologies. The project's main goals are two-fold. First, we
aim to employ a combination of unnatural cytosine analogs and helicase-deaminase fusions to perform
integrated long-read sequencing that preserves both genetic and epigenetic information, enabling the enrichment
and precise profiling of DNA modifications (5mC and 5hmC) in cfDNA from cancer patients. This approach will
facilitate the detection of cancer-specific modifications and potentially better pinpoint the tissue of origin in
unknown cancer samples. Second, we will develop a novel enzyme-based, single-cell barcoding, and
amplification strategy combined with long-read sequencing to map 5mC and 5hmC modifications in single-cell
epigenomes, particularly focusing on brain tissues. This will allow us to explore cellular heterogeneity and the
role of 5hmC in gene regulation within individual cell types. By leveraging our interdisciplinary expertise and
innovative methodologies, this project aims to redefine the boundaries of genomic research, providing a more
detailed and functional map of the human epigenome. This work will not only enhance our understanding of
basic sciences of human development and disease but also support the development of more effective
diagnostic tools based on epigenetic markers.

Public health relevance
PROJECT NARRATIVE Modifications to individual nucleobases in DNA play a crucial role in human development and human diseases. Our project aims to address the limitations faced by the current genomic tools through the creation of new non- destructive sequencing technologies that can localize the major modifications to DNA that shape gene expression. This advancement will empower researchers to study DNA more comprehensively, even with low input materials, and will thus be broadly applicable to different biological and biomedical questions.